Individual and family based approaches to increase physical activity in adolescents with IDD

Abstract
Adolescents with intellectual and developmental disabilities (IDD) are less physically active and have lower
cardiovascular fitness compared with their typically developing peers. Adolescents with IDD also face
additional barriers to participation in moderate-to-vigorous physical activity (MVPA) including dependence on
parents for transportation to exercise facilities, lack of appropriate exercise facilities, lack of PA professionals
with expertise regarding the specific needs of adolescents with IDD, and lack peer support. Previous
interventions to increase MVPA in adolescents with IDD have met with limited success, at least in part due to
requiring parents to transport their adolescent to an exercise facility, which represents significant barrier to
families already dealing with the burden of providing routine care for a special needs adolescent. We recently
developed a remote system to deliver MVPA, led by a trained health coach, to groups of adolescents with IDD
in their homes via video conferencing on a tablet computer. This approach eliminates the need for
transportation, provides social interaction and support from both the health coach and other participants, and is
feasible with minimal parent involvement. We propose an 18 mo. trial (6 mos. active, 6 mos. maintenance, 6
mos. no-contact follow-up) to compare changes in objectively assessed MVPA in 114 adolescents with IDD
randomized to a single level intervention delivered only to the adolescent (AO) or a multi-level intervention
delivered to both the adolescent and a parent (A+P). Adolescents in both intervention arms will be asked to
attend home-based, group MVPA sessions conducted by a trained health coach using video conferencing
software and to complete a weekly activity homework assignment. Parents of adolescents in the A+P group
will be asked to participate in the group video MVPA sessions and homework activity, attend
educational/support sessions with their adolescents regarding the role of MVPA in health and function and
strategies for increasing MVPA in both their adolescent and themselves, and will be provided access to a
Facebook page to interact with parents of other adolescents in the A+P arm. Our primary aim is to compare
mean increases in MVPA (min./d) between the AO and A+P groups from 0 to 6 mos. Secondarily we will
compare changes in MVPA, sedentary time, cardiovascular fitness, muscular strength, motor ability quality of
life and the percentage of adolescents achieving the US recommendation of 60 min. MVPA/d across 18 mos.
We will also explore the influence of process variables/participant characteristics including attendance at group
video (AO-adolescent; A+P-adolescent/parent) and education/support sessions (A+P only), self-monitoring of
MVPA (AO-adolescent; A+P-adolescent/parent), parental use of Facebook page (A+P only), peer
interactions/support during group PA sessions, adolescent self-efficacy, social support and barriers for PA,
parental MVPA, beliefs and attitudes toward PA and parental time constraints, age sex and IDD diagnosis.

Public health relevance
Project Narrative The development of effective scalable and sustainable intervention strategies to increase moderate-to-vigorous physical activity in adolescents with intellectual and developmental disabilities may improve cardiovascular fitness and quality of life, and reduce chronic disease risk.